Research Training for Substance Use Mediated HIV Epidemic in Kazakhstan/Aging Supplement

PROJECT SUMMARY/ABSTRACT
Limited knowledge exists about aging among people living with HIV (PLWH) in the Eastern European and Central
Asia (EECA) region including Kazakhstan (KZ). The intersection of aging with the HIV care continuum has never
been estimated in KZ and the EECA, and not evaluated among PLWH who are living to older ages and who
have high rates of substance use. Physical performance, daily functioning, frailty, disability, stigma, substance
use and resilience factors in PLWH must be characterized and repeatedly assessed across the HIV care
continuum to ensure quality of life with aging. This application is a supplement to the ongoing Fogarty D43 HIV
Research Training Grant on the Substance Use Mediated HIV Epidemic in KZ. We will train one Early Stage
Investigator (ESI) by accomplishing two Aims. Aim 1 includes advanced didactic training in HIV-aging and
Gerontology via two well-established (one NIH-funded) programs in the US, plus scientific meeting attendance,
a monthly journal club and seminars. Aim 2 includes collecting pilot data on key aging metrics. The ESI will
assess physical performance using the Short Physical Performance Battery, which includes: hand grip strength,
4 meter walk, chair stands, and balance (side-by-side, semi-tandem, and tandem stand). Daily functioning and
disability will be assessed via the Lawton Instrumental Activities of Daily Living (IADL) scale. Frailty will be
calculated according to the Fried Frailty Phenotype (FFP), which is comprised of grip strength, 4 meter walking
speed, physical exhaustion, low physical activity, and unintentional weight loss. The ESI will also measure stigma
and resilience using validated stigma scales for HIV stigma, aging stigma, and the 10-item Connor-Davidson
Resilience Scale. Sociodemographic and HIV variables including HIV viral load and CD4+ count will be
assessed. Our ESI training plan supports implementation of our pilot research study, with the hypothesis is that
the prevalence of lower physical performance and daily functioning, manifestation of the FFP, disability, and
higher levels of HIV and aging stigma will be observed among KZ PLWH compared to PLWH in high income
countries. This will be exacerbated among PLWH who are poorly controlled, HCV co-infected, injection drug
users, older, and men. We also hypothesize that noncommunicable disease (NCD) co-morbidities and higher
levels of HIV and aging stigma will be associated with manifestation of the FFP and disability, and be more
prevalent in PLWH who are less resilient. This innovative combination of advanced didactic plus hands-on
research training in HIV-aging of one Kazakh ESI is the first in KZ and EECA and achievable in one year. Pilot
study results will inform 1) development of interventions to address chronological aging together with the
HIV/NCD care continuum among PLWH in KZ, and 2) provide a foundation for prospective observational studies
designed to compare aging processes between PLWH and people without HIV in KZ.

Public health relevance
PROJECT NARRATIVE Aging-related decline in physical performance and daily functioning is common among people living with HIV (PLWH) who are >40 years old and may engage in harmful lifestyles that exacerbate aging outcomes. Declining physical performance leads to frailty, which challenges one’s ability to perform activities of daily living and disability, affects quality of life and may lead to HIV and aging stigma and lower resilience. These facets of HIV- aging are virtually unknown globally, and especially in low- and middle-income countries in Eastern Europe and Central Asia including Kazakhstan, where we propose to train one Early Stage Kazakh investigator using didactic methods and hands-on pilot research project implementation.